Roles for virus-derived circular RNAs during RNA virus infections

Project Summary/Abstract
Powerful direct-acting antivirals against hepatitis C virus (HCV) are available, but no vaccine is available.
There are no effective antiviral compounds available to treat enterovirus 71 (RV71) that can cause severe
neurological complications in children. In the case of SARS-CoV-2, powerful vaccines are available, but the
rapid emergence viral variants warrant the continued development of novel antiviral approaches. Thus, it is
important to continue to search for novel vulnerabilities in these RNA viruses. We have made the astonishing
discovery that HCV-, EV71- and SARS-CoV-2-infected cells produce hundreds of virus-derived circRNAs
(vcircRNAs) species of different sizes that are derived from the viral RNAs. Some of these vcircRNAs, such
as the HCV internal ribosome binding site (IRES)-containing cluster I vcircRNA of HCV, are being translated
to yield novel viral proteins with pro-viral functions. We also made the puzzling observation that the 3' end of
the minus-strand of HCV contains an IRES that mediates the translation of a novel minus-strand protein
(MSP) that is unique to the JFH1 type 2a genotype. Our hypothesis is that vcircRNAs modulate viral and
cellular gene expression and function in infected cells to elicit novel pro-viral or anti-viral responses. The
rationale for this proposal is that modulation of vcircRNA abundances affect the pathogenesis of HCV, EV71
and SARS-CoV-2. Our goals are to examine the functional roles for the vcircRNAs in human cultured liver
cells, human liver organoids and lung A549-ACE2 cells, using bioinformatic, genetic, biochemical and cell
biological approaches. Two specific aims are proposed to accomplish these goals. First, functional roles for
abundant vcircRNAs and IRES-containing vcircRNAs in viral gene expression will be examined after
depletion of vcircRNAs, using the Cas13-gRNA system, and after ectopic expression of in vitro-synthesized
vcircRNAs. Analyses of intracellular vcircRNA localization and protein-vcircRNA interactions will be
performed to gain mechanistic insights into the actions of vcircRNAs. The second aim we will test the
hypothesis that the vcircRNAs are generated by cytoplasmic RNA ligases, such as the RTCB/archease
ligase complex, that is involved in tRNA ligation and XBP1 mRNA splicing during the unfolded protein stress
response, or the newly identified C12ORF29 ligase are involved in the formation of vcircRNAs. The expected
outcomes from this application will address fundamental aspects about the functions of novel vcircRNAs and
novel viral proteins in the viral infectious cycle. We hypothesize that other RNA virus families generate
vcircRNAs as well, suggesting novel Achilles’ heels in viruses that can be targeted in novel antiviral
approaches.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health, because it examines how virus-derived circular RNAs aid in the genome amplification of several RNA viruses, such as hepatitis C virus that causes cirrhosis and eventual malignant transformation of the liver, of enterovirus 71 that causes neurological diseases, lung difficulties and mortality, and of SARS-CoV-2 that causes COVID. While there are some very promising direct acting viral compounds for HCV, they are not affordable for everyone worldwide, none are available for EV71, and the COVID vaccines need to constantly be refined. The project is relevant to NIH’s missions to support discoveries that lead to new venues to prevent and to cure viral disease.